Erythrocyte-derived particles for near infrared phototherapy of port wine stains.

Port wine stain (PWS) is a congenital and progressive malformations of the dermal capillaries.
Pulsed dye laser (POL) irradiation in the visible wavelength range of 585-600 nm remains
as the gold standard of treatment. The underlying treatment principle is based on the
absorption of POL light by hemoglobin to induce irreversible photothermal coagulation of the
vasculature. However, therapeutic efficacy with POLs remains limited due to insufficient
penetration of light in skin, and non-specific absorption by the epidermal melanin pigments.
Clinically acceptable outcomes are achieved in only about 20% of patients with diminishing returns
beyond five treatment sessions. Our long-term objective is the development of a new therapeutic
approach based on intravascular administration of optical micro-particles, fabricated from
erythrocytes, as targets for pulsed near infrared (NIR) laser treatment at 755 nm. These
micro-particles are doped with indocyanine green (ICG), the only FOA-approved NIR chromophore. The
underlying premise is based on reduced absorption of light by melanin, strong ICG absorption,
and availability of dermatological lasers at 755 nm. A particularly innovative feature of
these micro-particles is that their membrane is enriched with cholesterol to prevent the flipping
of phosphatidylserine from the inner to the outer leaflet of the membrane, which would
otherwise serve as a signal for removal of the particles from the vasculature. We refer to these
micro-particles as c⁺- µNETs. By using c⁺-µNETs, we aim to prolong the circulation time of ICG, and
increase its availability in the lesion vasculature so that more sites can be treated
during a given session, ultimately leading to minimal therapeutic sessions to clear the
stain. Another innovative aspect is the use of transgenic mice whose melanin content can be
varied in a controllable manner to simulate the epidermal response of PWS with
different pigmentations to 755 nm laser irradiation. We will use these mice to determine the
threshold values of the laser radiant exposures for epidermal injury and blood vessels
photocoagulation in conjunction with c⁺-µNETs. We will also use a rabbit model to
characterize the circulation and biodistribution dynamics of c⁺-µNETs, determine the
therapeutic window of time when using c⁺-µNETs, and evaluate the vascular response as it relates
to laser irradiation parameters and dose of c⁺-µNETs. SA 1: Fabricate and characterize c⁺-µNETs. SA
2: Characterize the circulation and biodistribution dynamics of c⁺-µNETs. SA 3: Evaluate
the therapeutic efficacy of c⁺-µNETs in conjunction with pulsed NIR laser irradiation. A key
outcome of our proposed studies is that we will know the maximum length of time over which
effective blood vessels photocoagulation can be achieved when using c⁺-µNETs, in addition to
finding the appropriate radiant exposure levels for vascular photocoagulation in skins
with various pigmentations. This knowledge is not currently available, but is essential
towards development of safe and effective protocols for laser treatment of PWS patients. Proposed
studies are consistent with the scientific themes of NIAMS in developing effective therapies for
PWS.

Public health relevance
Port wine stains (PWS) is a congenital and progressively deteriorating skin disease with psychological and physical complications. Despite the current therapeutic approach based on pulsed visible laser irradiation, treatment effectiveness is limited to only about 20% of the patient population. Using animal models, investigators propose studies to evaluate the efficacy of optical micro-particles fabricated from red blood cells, and enriched with cholesterol for use in conjunction with pulsed near infrared laser irradiation as a potentially new treatment approach for broader patient population.